P30-Core Grant for Vision Research Core C

The overall goals of the Biostatistics and Bioinformatics (Bioanalysis) Core are to improve the quality, and
increase the quantity of research conducted by NEI-R01 holders in the Atlanta (AVRC). This is done through
better and faster biostatistics and informatics approaches than those that the typical PI can conduct by himself
without Core support. The Bioanalysis staff benefits from formal rigorous mathematical training in biostatistics
and informatics for interpretation of experimental results, so that NEI-R01 PIs do not need as much
biostatistics and informatics training to effectively design experiments and interpret results. The Bioanalysis
Core:
1. Provides better resources and more convenient access to state of the art analysis tools than an NEIR01
PI could provide or support alone.
2. Consults with PIs to determine scope of a project, timeframe, services needed.
3. Conducts work that would otherwise require hiring of bioinformatics and biostatistics experts that is
impractical for an R01 budget.
4. Provides training to PIs and personnel as appropriate for more routine tasks.
5. Pre-tests and troubleshoots data and software from bleeding edge technologies to avoid repeated mistakes
by multiple individual PIs.
These Aims serve to maximize the utility of each R01 experiment and enables experiments that otherwise
could not be conducted or analyzed. The Bioanalysis Core leverages and facilitates usage of university level
resources and talents from among the five institutions that make up the AVRC.

Public health relevance
Narrative sections are not allowed for the Admin, and Cores A, B, and C modules according to PA-20-051.